Adolescent alcohol exposure exacerbates rmTBI associated BBB disruption and dementia risk

Title: Adolescent alcohol exposure exacerbates rmTBI associated BBB disruption and dementia risk
Approximately 20% of adolescents self-report experiencing one or more mild traumatic brain injuries (mTBI) with
adolescent athletes being at a higher risk than non-athletic peers. Additionally, rates of alcohol consumption are
higher in adolescents participating in team sports. The adolescent brain is especially vulnerable to both insults.
Over the years, dementia has been linked to a variety of diseases and injuries, among them alcohol consumption
and TBI, with repeat mild TBI (rmTBI) believed to be the primary factor in the development of chronic traumatic
encephalopathy (CTE) a neurodegenerative disease that leads to dementia. Dementia is a leading cause of
disability and dependency worldwide, with an estimated annual cost of $1.3 trillion (US). One important brain
feature that is disrupted by TBI and alcohol, as well as being heavily implicated in the development of dementias,
is the blood-brain barrier (BBB). The BBB is an intricately linked cellular and molecular structure that maintains
homeostasis in the microenvironment of the brain by regulating the access of blood-borne molecules into the
tissues, and critically the BBB plays a role in the production and clearance of amyloid beta. Alcohol has been
shown to disrupt the BBB via a cascade of pathological events, such as the release of inflammatory cytokines,
accumulation of extracellular adenosine, and the reduction of tight junction integrity. While TBI initially disrupts
the BBB via shearing and rupturing forces of the mechanical injury, it also subsequently leads to a similar
cascade of events as alcohol. The proposed studies will use adolescent female and male rats subjected to a
series of four mTBIs interspersed with episodes of alcohol exposure to test the hypothesis that adolescent
alcohol exposure exacerbates repeated mild traumatic brain injury (rmTBI)-induced damage to the BBB and
increases expression of dementia-related markers. Proof of principle studies will use pharmacological
approaches to examine whether alcohol-mediated enhanced BBB disruption contributes to the increased risk for
dementia.

Public health relevance
NARRATIVE The neurobiological basis for the co-morbidity between repeat mild traumatic brain injury (rmTBI), intermittent alcohol exposure (IAE) during adolescence, and dementia remains unclear. This proposal will utilize animal models of rm TBI and IAE during adolescence to examine the role of blood-brain barrier (BBB) disruption and how that may drive the development of dementia-associated proteinopathies in adulthood. The results of this work may provide a new therapeutic treatment to treat humans following TBI.